Program 10 Cancer Care Delivery Research

Cancer Care Delivery Research Program
Project Summary / Abstract
The mission of the Cancer Care Delivery Research (CCDR) Program is to facilitate and conduct research that
ensures the delivery of high-quality, patient-centered care to individuals with all types of cancer. Advances in
cancer diagnosis, screening, prevention, and treatment are usually tested and reported in defined and
relatively small groups of research subjects. Members of the CCDR Program measure the extent to which
interventions are effective when the reported advances are scaled population-wide. The Program develops,
refines, tests, and implements strategies to maximize the impact of discoveries. A particular point of emphasis
is the degree to which the benefits of research discoveries extend to patients from racial and ethnic minority
backgrounds and to those who are socioeconomically disadvantaged.
The Program has 66 members (56 primary and 10 secondary), representing all seven DF/HCC institutions and
12 academic departments. In 2019, peer-reviewed grant funding attributed to the Program was $5.1 million in
direct costs from the NCI and $7.7 million from other sponsors. During the current funding period, primary
CCDR members published 1,336 cancer relevant papers. Of these, 25% were inter-institutional, 23% were
intra-programmatic, and 39% were inter-programmatic collaborations between two or more DF/HCC members.
CCDR’s emphasis on improving the experience, efficiency, and equity of cancer care ensures that innovations
in cancer treatment and care realize their full potential throughout populations and care settings. To meet the
Program mission, CCDR members have built successful collaborations, developed new research methods,
constructed data sources, and trained the next generation of clinical investigators. Our Specific Aims for the
next CCSG funding period are to: 1) Assess the quality, effectiveness, and value of new and established
interventions to treat cancer, with an emphasis on precision medicine by (a) designing clinical informatics
strategies to improve cancer care delivery and (b) promoting capacity for delivering precision medicine; 2)
Evaluate patient-centered outcomes of cancer care, including health-related quality of life and symptom burden
by developing tools to assess the patient experience; 3) Assess the impact of healthcare reform, including
alternative delivery, coverage, and reimbursement systems on cancer screening, diagnosis, treatment, and
outcomes; and 4) Develop and test strategies to improve palliative and end of life care (EOL) experiences for
advanced cancer patients and their families.

Public health relevance
Project Narrative Not Applicable.